Neurobiological Basis of Reference Frame Coordination for Spatial Memory to Action Transformations

PROJECT SUMMARY/ABSTRACT
Guiding movements through space and establishing enduring memories based on such experiences is
essential for the survival of all animals including humans. This ability is thought to require storage of
memories, often in an allocentric (map-like) framework, and their conversion into a body-centered reference
frame, comprised of specific locomotor actions (e.g., turning right). These frameworks must be coordinated
in a fluid manner during navigation, involving both person-centered and person-independent information.
Impairments in accurate navigation are often a result of spatial disorientation, which can involve a general
loss of directional sense in allocentric coordinates (e.g., the goal is to the north) or deficits in determining
the location of objects or goals in relation to one’s body orientation in egocentric coordinates (e.g., the goal
is to my right). While the neural mechanism of these deficits may involve a distinct loss in specific spatial
reference frames, impairments may also reflect a loss in transformation across reference frames, such as
determining the appropriate action for an allocentric location and orientation (e.g., turning right when oriented
north at a specific location). The neurobiological basis of information processing in allocentric and action
reference frames is thought to involve a circuit, including the parietal cortex (PC), anterior thalamic nuclei
(ATN), retrosplenial cortex (RSC), and the hippocampus (HPC). The encoding observed in ATN, HPC and
PC has led to the notion that this network operates as a coordinate transformation system, enabling the
coordination of these reference frames for spatial memory, such as transforming a remembered allocentric
representation into the appropriate actions. While this is an attractive hypothesis, little is known about
whether such coordination between reference frames takes place and, if so, what the underlying circuit
dynamics are between the HPC, ATN and PC. These observations inspire our central hypothesis that the
HPC-ATN-PC network is critically involved in the coordination between spatial allocentric memories and an
appropriate action. Our proposal tests this hypothesis using a new task we developed in two aims directed
at: 1) Determining whether the HPC-PC circuit encodes map and action information, looking for evidence of
the computations underlying allocentric-egocentric transformations across the HPC-RSC-PC network, and
determining if the HPC-PC circuit is critical for generating an action dependent on spatial memory (i.e., map-
to-action). 2) Determining whether the ATN-PC circuit contains transformation information and is critical for
the transformation from a map to action. This proposal will provide critical insight into a hippocampal-
thalamo-cortical network that has received very little attention with respect to its role in spatial behavior. It
represents an important step toward building a complete understanding of the neurobiological bases of
dysfunctional spatial learning and memory, which occur in many psychiatric and neurodegenerative
disorders such as schizophrenia, post-traumatic stress disorder, depression, and Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE Deficits in spatial learning and memory occur in many psychiatric and neurological disorders (e.g., schizophrenia, posttraumatic stress disorder, depression, Alzheimer’s disease, stroke, and traumatic brain injury), and the neural mechanism of these deficits may involve a distinct loss in specific spatial reference frames or a loss in coordination across reference frames, such as determining the appropriate action for an allocentric location and orientation (e.g., turn right when oriented north at a specific location). Further investigation of these basic neurobiological mechanisms underlying spatial navigation is critically important for establishing a complete understanding of the neural underpinnings of spatial deficits in psychiatric disorders, neurological disorders, brain disease, and stroke. Such investigation will facilitate the development of more precise diagnostic tools and therapeutic interventions to help manage or reverse these diseased and disordered brain states and on a broader level, it will further our understanding of the neural basis of episodic memory, recognizing objects from a variety of viewpoints, and potentially even inform understanding of basic organizing principles of the brain.